GenePAL: A Portable Approach to Longitudinal Genomic Healthcare for Infants

ABSTRACT/SUMMARY
Rare diseases, many of which are genetic and present early in life, disproportionately contribute to pediatric
morbidity, mortality, and healthcare spending. Early identification of a precise genetic diagnosis may lead to
improved genetically-informed care across the lifespan. One mechanism by which early genetic diagnosis may
lead to improved healthcare and health outcomes is through improved surveillance for and management of
known complications of the condition. However, families face many barriers to recommended plans of care,
including lack of care coordination and limited access to subspecialty services due to geographic or resource
constraints. At the same time, community providers who facilitate the follow-through for these infants may have
difficulty interpreting genetic testing results and determining appropriate management of these conditions. The
end result is a failure to fully realize the benefits of early genetic diagnosis. We plan to address this problem via
GenePAL (Portable Approach to Longitudinal Genomic Healthcare for Infants): a pilot study of a novel, web-
based application (“Nest”) optimized for mobile devices to empower families to understand and obtain
appropriate follow-up care via personalized healthcare plans. In Aim 1, will plan a mixed-methods approach that
is informed by the Consolidated Framework for Implementation Research to refine, implement, and preliminarily
evaluate Nest: we will conduct surveys and semi-structured interviews to identify priorities and vales of parents
and healthcare providers, the results of which will be used to refine Nest. In Aim 2, we will implement Nest in a
prospective cohort of infants diagnosed with rare genetic conditions, developing a genomic care plan for each
infant. Finally, in Aim 3 we will evaluate Nest in terms of the key implementation outcomes of acceptability and
appropriateness through semi-structured interviews with parents and providers who interacted with the care
plans generated in Aim 2. The findings from this pilot study will inform broader implementation of Nest, toward
the goal of improved health outcomes for infants, optimized management, and a fuller realization of the promise
of early genetic diagnosis. The data generated from this study will also provide critical insight into the role of
patient-facing clinical informatics tools for management of genomic diagnostic information in pediatric rare
disease that will drive other future studies to improve implementation of genomic-empowered healthcare.

Public health relevance
NARRATIVE Advances in genomic diagnostic techniques have helped identify underlying diagnoses for many infants and young children with rare conditions, although barriers to follow-through care after the diagnosis is made threatens the ability of genetic diagnoses to have a meaningful impact on health and health-related quality of life. Our overarching goal is to translate early genetic diagnoses into sustainable improvements in clinical care and health- related quality of life across the lifespan. The GenePAL (Portable Approach to Longitudinal Genomic Healthcare for Infants) pilot study represents a critical step towards that goal by refining, implementing, and evaluating early implementation outcomes of a web-based application (“Nest”) that aims to improve genomic care following rare disease diagnosis in infancy towards improved health and quality of life.